Structural bases for protein synthesis quality control

PROJECT SUMMARY
Accurate and faithful ribosome-directed protein synthesis is an essential step of gene expression. During this
process, the codons in mRNAs are systematically decoded by tRNAs with the assistance of translation protein
factors. The bacterial ribosome is the target for the majority of antibiotics used in hospital settings and therefore,
understanding how the ribosome monitors the quality and accuracy of synthesized proteins could provide
unanticipated opportunities for the development of new and improved therapeutics. Whereas the function of
canonical translation factors has been studied for decades, the mechanisms by which the same protein factors
control the quality of protein synthesis are enigmatic. This represents an aspect of translation regulation that has
remained largely unexplored. Several of the quality control steps are mediated by canonical translation factors,
such as release factor 3 (RF3) and initiation factor 2 (IF2). RF3 is known to recycle translation termination factors
RF1 and RF2 from the ribosome; however, RF3 is also implicated in the release of the nascent peptide chain
from mismatched ribosome complexes, in peptidyl-tRNA drop-off, and co-translational protein folding. Similarly,
besides ensuring accurate and timely initiation of protein synthesis, IF2, together with initiation factor 1 (IF1), can
monitor translation by stimulating peptidyl-tRNA drop-off, suggesting that IF1 and IF2 can function on elongating
ribosomes. My group recently elucidated the mechanism of GDP exchange in RF3 catalyzed by the ribosome
termination complex, illustrating how the ribosome can function as the guanine nucleotide exchange factor (GEF)
for RF3. Our cryo-EM structures of the 70S ribosome simultaneously bound to RF3 and RF1, and to IF1 and
IF2, provide a solid foundation for us moving forward to investigate fundamental aspects of translation quality
control in bacteria mediated by RF3, as well as by IF1 and IF2. We further propose to elucidate how non-
canonical translation factors, such as elongation factor 4 (EF-4) and ATP-binding cassette family (ABCF)
proteins, modulate the conformation of the P-site tRNA and of the attached nascent peptide chain to rescue
translationally compromised ribosomes and confer antibiotic resistance. Altogether, the proposed studies will
provide mechanistic insights into the function of canonical and non-canonical translation factors in protein
synthesis quality control and rescue of stalled ribosomes, and in the long-term may offer unsuspected therapeutic
opportunities for the treatment of bacterial infections.

Public health relevance
NARRATIVE Protein biosynthesis, mediated by the ribosome in all cells, is an essential step of gene expression and is thus fundamental to all cellular functions. During translation, the ribosome encounters a plethora of roadblocks as it progresses along mRNAs, necessitating quality control mechanisms to ensure protein synthesis accuracy, efficiency, and stalled-free translation. The proposed work will provide insights into the safeguard mechanisms that regulate bacterial translation, facilitating the development of targeted antimicrobials.